Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes

Older women experience dramatic changes in the hypothalamic-pituitary-gonadal (HPG) axis and female
reproductive hormones, producing vasomotor symptoms (VMS), sleep problems, cognitive changes, and
cardiometabolic risks, which increase susceptibility to cardiovascular disease (CVD) and dementia. VMS occur
in 85% of women and persist in one-third for 10+ years after menopause, potentially leading to prolonged
disruption of quality of life, sleep disturbance, cardiometabolic risk, and extended VMS treatment, conferring
further risk for CVD and dementia. Such health outcomes may also be influenced by stress exposures across
the lifespan and during pregnancy, which may exert their effects through neural mechanisms. Brigham and
Women’s Hospital (BWH) and Harvard Medical School (HMS) seek to establish a SCORE to advance our
understanding of stress exposures and neural regulation of reproductive aging health outcomes, and to catalyze
growth of translational women’s health and sex-differences research in aging women. We will pursue novel
translational science through three Projects: Project 1 (Joffe/Mahon; clinical science) will define evoked stress
responsivity, stress-related activation of neural networks on functional brain imaging, and GABA concentrations
as markers of VMS occurrence and persistence, including compounding effects of poor sleep and stress
exposures. Project 2 (Oken/Chavarro; population science) will determine whether perimenopausal women with
higher exposure to social stressors across the lifespan and physiological stressors across pregnancy have
greater cardiometabolic risk, sleep, cognitive, and neuropsychiatric symptoms. Project 3 (Kaiser/Navarro; basic
science) will characterize the role of kisspeptin, neurokinin, and dynorphin (KNDy) neurons and upstream
GABAergic neurons in mediating the effects of stress and corticosteroids on the HPG axis, VMS, and sleep
disturbances in a rodent model. These scientific efforts will receive critical support from our Cores: The Sleep
Resource Core (Klerman) will extend our scientific impact by investigating sleep outcomes in humans and
rodents. The Career Enhancement Core (Rexrode/Rich-Edwards) will promote early-career and new sex-
differences investigators by supporting Scholars, Pilot Projects, Travel Exchange Fellowships, and a robust
educational program. The Leadership Administrative Core (Joffe/Manson) will provide scientific and
administrative oversight and engage with the SCORE Consortium. Building on existing, fruitful collaborations,
our outstanding interdisciplinary team of investigators—leaders in women’s health, sleep medicine,
neuroimaging, neuroendocrinology, stress science, cognition, cardiometabolic, and reproductive epidemiology—
will leverage robust resources at the Connors Center for Women’s Health and Gender Biology and across
synergistic women’s health and sleep programs at BWH. This SCORE will produce a significant public health
impact by advancing our understanding of the role and mechanisms of stress in producing reproductive aging
health outcomes that are linked with CVD and dementia susceptibility in aging women.

Public health relevance
SCORE NARRATIVE The Brigham and Women's Hospital/Harvard Medical School SCORE Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes will address an important knowledge gap in our understanding of how 1) social and metabolic stress exposures that are more common or unique in women result in health problems during and after menopause—bothersome hot flashes, sleep problems, body fat gain, heart disease; and 2) dissect the brain circuity’s response to stress that drives these health changes during and after menopause. Our Brigham/Harvard SCORE will catalyze women’s health and sex/gender difference research and grow the next generation of investigators in this field. Results of our studies will produce a significant public health impact in aging women by understanding the role and mechanisms of stress in producing midlife women’s health outcomes that are linked with cardiovascular disease and dementia.